Development of the ADRD Systematic Hospital Inclusion Family Toolkit: A-SHIFT

ABSTRACT
The U.S. healthcare system relies on an estimated 11 million unpaid (family and friend) care partners to provide
care to people living with Alzheimer’s disease and related dementias (ADRD) after hospitalizations. Despite
acknowledgement that care partners are critical to optimizing health outcomes of patients living with ADRD after
hospitalization, care partners report dissatisfaction with their inclusion during the hospitalization process. Care
partners feel ill-equipped to assist in tasks when the person living with ADRD returns home. Identification,
assessment, and training are critical to equip care partners to fulfill caregiving tasks for people living with ADRD
after hospitalization. We propose to develop the ADRD Systematic Hospital Inclusion Family Toolkit (A-SHIFT);
which will provide healthcare systems practical guidance regarding how to identify, assess, and train care
partners of hospitalized people living with ADRD. A-SHIFT will be developed in accordance with the NIH Stage
Model and leveraging perspectives from collaborative partners that include leading aging and caregiving
scientists, healthcare systems and clinicians, and people living with ADRD and their care partners. Specifically,
for Aim 1 we will characterize patterns of care partner inclusion in hospital care for people living with ADRD; for
Aim 2 we will identify and prioritize healthcare system facilitators and barriers to the inclusion of care partners in
hospital care for people living with ADRD; and for Aim 3 we will co-design the A-SHIFT to facilitate the inclusion
of care partners of hospitalized people living with ADRD. To address these aims, we will use a convergent mixed
methods design with systems engineering methods. In Aim 1, we will conduct direct observations of clinician
interactions with hospitalized people living with ADRD and present care partners and extract workflow-related
data from electronic medical records to understand contemporary practice for identifying, assessing, and training
care partners. In Aim 2, we will interview and survey key stakeholders to identify and rate facilitators and barriers
for care partner identification, assessment, and training. In Aim 3, we will convene two design teams consisting
of key stakeholders that will work in parallel to develop the A-SHIFT. Successful completion of the proposed
aims will result in an A-SHFT prototype, which we will subsequently test for feasibility followed directly by a hybrid
efficacy/effectiveness trial testing A-SHIFT’s effectiveness at increasing care partner preparedness and reducing
avoidable hospital readmissions by people with ADRD. As a result of this work, we expect care partners to
receive meaningful inclusion during the hospitalization of people living with ADRD with the help of A-SHIFT.

Public health relevance
PROJECT NARRATIVE We will use a systems engineering approach to develop the Alzheimer’s disease and related dementias (ADRD) Systematic Hospital Inclusion Family Toolkit (A-SHIFT) to prepare care partners of people living with ADRD for their caregiving responsibilities after hospital discharge. A-SHIFT will provide healthcare systems strategies on when and how to identify care partners, tools for assessing care partner needs and preparedness, and methods for training them to meet caregiving demands.